University of Washington Significant Opportunities in Addiction Research (UW-SOAR) Neuroscience Doctoral Readiness Program

Project Summary
Neuroscience research and training have seen tremendous growth in recent years. Of note, this
progress has extended into the study of psychiatric disorders, which has increased our knowledge
around the neurobiology and mechanisms underlying drug use and addiction. Nonetheless, this
growth has not translated into training opportunities for historically marginalized groups, including
ethnic minorities, people from economically disadvantaged groups and people with disabilities.
These disparities in training, mentoring and education are particularly concerning for the study of
addiction, as the harms related to drug use and addiction disproportionally affect minority and
underserved communities. Thus, it remains critically important that our mentoring of the next
generation of neuroscientists is reflective of all the diverse groups in our society. We recognize
that research experience is not only a key factor in bolstering awareness and interest in
neuroscience careers, but also in the admittance and successful completion of neuroscience PhD
programs. Furthermore, we believe that the historic underrepresentation of marginalized groups
in neuroscience stems, in part, from a lack of research opportunities in these groups during their
undergraduate education. Thus, the primary objective of the University of Washington Substantial
Opportunities in Addiction Research (UW-SOAR) Doctoral Readiness Program is to close this
gap of training by providing diverse groups with a mentored research experience in a world-class
neuroscience laboratory in the UW NAPE (Neurobiology of Addiction, Pain and Emotion) Center.
This experience will be coupled to unique educational and professional development opportunities
to facilitate their recruitment and success in neuroscience doctoral programs. To achieve this
goal, our program aims to 1) increase representation across multiple dimensions of difference
(race, ethnicity, gender, sex, geography, ability, etc.) among postbaccalaureate researchers to
improve the quality and diversity of science, 2) advance the matriculation and retention of diverse
groups of trainees in Neuroscience PhD programs, and 3) determine the effectiveness of the
SOAR program through an evaluation process.

Public health relevance
Project Narrative This postbaccalaureate training program is designed to provide two-year research opportunities and professional development activities to recently graduated people from diverse backgrounds that were at an undergraduate institute with limited research opportunities. Program participants are expected to develop novel research projects that will provide important new insights into the neurobiology underlying drug use and addiction. The research and education activities of the program will prepare the program participants for successful matriculation into neuroscience- related Ph.D. or M.D./Ph.D. programs.